ADMINISTRATIVE CORE

The Administrative Core (Core A) will include an Administrative Assistant (Ms.Isolde Bates) who will ensure the accurate and efficient management of the financial aspects of the research budgets, including facilitating ordering of supplies and providing accurate forecasting of remaining resources. The Administrative Assistant interfaces with Central Grants Administration,the Purchasing Department, Human Resources, and other UConn Health Center Administrative units. The Core will also maintain common data bases available to the investigators for references, available clones and reagents, and scientific protocols. One of the major benefits of the AdministrativeCore is that it frees the Pis and research staff from the many day- to-day details involving purchasing and financial record keeping, so that they can focus on the scientific aspects of the Program.